CRISPR tools to dissect the coding and non-coding genome

In the early years of our laboratory we have developed computational strategies to minimize the impact of gRNA specificity on the output of CRISPR screens, an essential requirement when applying them to regulatory sequences-such as miRNA binding sites-whose disruption can have subtle impacts on cellular behavior. We have provided this expertise to design focused as well as genome-scale libraries for many of our colleagues. Because the CRISPR tools we have developed have implications beyond RNA-centered research, we have been approached by Dr. Raj Chari (heads of the NCI Genome Editing Core) to help them generate new genome-wide and focused libraries with optimized gRNA designs. These libraries are now available free of charge to NIH researchers via the Genome Editing Core as plasmids or viral aliquots and have been used by dozens of laboratories.